Multi-scale model of microbial phenotype modulation by mucins

Mucus provides a critical protective barrier against infectious agents; its role in the clearance of microorganisms
from the lung [1] is long-appreciated. Recent studies by our team [2,3] on the modulation of microbial
phenotypes by mucins, glycoproteins that are a primary component of mucus, are creating a whole new
appreciation for the complexity of interactions in the mucosal layer. However, to date, our understanding is limited
to cataloging the components in this complex milieu with little understanding of the mechanisms underlying the
phenotypes that emerge from the interactions of microbes and mucins. Understanding the mechanistic mucin-
driven modulation of microbial phenotypes is of paramount importance in multiple diseases including cystic
fibrosis, a disease characterized by defective clearance of mucus [4]. There is emerging evidence that mucin
alters the transport of secreted factors and elicits changes in gene regulation in microbes [1,5]. Recently
developed metabolic models by our team of P. aeruginosa (a key pathogen in cystic fibrosis) can explicitly
account for the connection between these changes in gene regulation and the metabolic functionality of the
bacterium in these complex environments [6]. The underlying central hypothesis to the proposed work is that
microbial phenotypes are a function of mucin-modulated transport- and metabolism-related properties. An
integrative, multi-scale computational model will be constructed to guide experimental design and facilitate
understanding of emergent microbe-mucin phenomena. We will develop a framework for integrating metabolic
network models with continuum models of transport phenomena using agent-based models that can serve as a
template for similar multi-scale modeling challenges. Specifically, we will address the following questions: (1)
How do mucins modulate the metabolism of microbes? (2) How do mucins alter transport of microbes
and metabolites? (3) What are the key metabolic- and transport-related modulators of clinically-relevant
phenotypes of a microbe in mucus? The importance of a mechanistic understanding of the underlying complex
interactions of microbes, mucins, metabolites, and transport phenomena cannot be overstated; for example,
acute lower respiratory tract infections, driven by the interaction between mucus and microbes, are a critical
global health problem with a greater burden of disease than cancer, heart disease, malaria, and HIV [7]. Our
team of experts in computational modeling, microbial physiology, and mucus biology is well poised to tackle this
complex problem. We will establish a framework for computational modeling of metabolism and transport in
mucosal environments and identify key modulators of Pseudomonas phenotypes. We will be able to predict and
control biofilm dispersion through modulation of the mucosal environment, resulting in the potential for more
effective antibiotic targeting and ultimately strategies to treat P. aeruginosa infections and other diseases in
which a disrupted mucosal interface is important. This framework will serve as a template for the predictive value
of such models to interrogate complex microbe-human host interactions for many other applications.

Public health relevance
The importance of a mechanistic understanding of the underlying complex interactions of microbes, mucins, metabolites, and transport phenomena cannot be overstated; infections of human mucosal layers are a critical global health problem with a greater burden of disease than cancer, heart disease, malaria, and HIV [7]. Our team of experts in computational modeling, microbial physiology, and mucus biology is well poised to tackle this complex problem. We will establish a framework for computational modeling of metabolism and transport in mucosal environments, resulting in the potential for more effective antibiotic targeting and ultimately strategies to treat diseases in which a disrupted mucosal interface is an important factor.